Reaching for the end of pediatric AIDS: Modeling strategies to strengthen the maternal-child HIV care continuum and eliminate vertical HIV transmission.

Despite substantial progress in preventing infant HIV infections, an estimated 160,000 new pediatric infections still occur each year worldwide, primarily due to gaps in testing and care for pregnant and lactating women with HIV. The World Health Organization (WHO) and UNAIDS have issued an ambitious call to end pediatric HIV by 2030. With NICHD support, R01HD079214 has launched development and growth of the CEPAC-Pediatric model, a detailed microsimulation model of HIV in children in Côte d’Ivoire, South Africa, and Zimbabwe. CEPAC-P analyses focused on diagnosis and treatment of HIV have been cited in every published WHO HIV Guideline since 2013. In the next award cycle, we propose to address the crucial question: what will it take to drive infant HIV infections as close to zero as possible? Meeting this ambitious goal will require not only pediatric interventions, such as improved postnatal prophylaxis for infants born to women with HIV, but also bold and creative interventions for pregnant and lactating women with or at risk for HIV to prevent, diagnose, and treat maternal HIV before infant infection occurs. Both pediatric and maternal interventions are needed, but neither can be considered in isolation; the choice of maternal interventions will determine what infant interventions are clinically most useful and provide good economic value. We will conduct CEPAC model-based policy analyses of individual maternal and infant interventions. We will then develop, test, and apply simulation optimization methods to identify the package of these interventions that minimizes infant infection risk, improves infant and maternal health, and provides the best value for limited healthcare resources in each of the three focus countries described above. Our Specific Aims include:
Aim 1: To estimate the clinical outcomes and cost-effectiveness of maternal HIV testing, prevention, and treatment approaches to reduce vertical HIV transmission and improve maternal health
Aim 2: To identify the most effective and cost-effective infant HIV prophylaxis and testing strategies
Aim 3: To optimize integrated maternal-child HIV prevention and treatment approaches
To make the findings of this work more broadly applicable, we will identify optimal packages of care in three WHO-defined country “types,” based on HIV incidence, prevalence, and access to care. To make the findings accessible to clinicians, program planners, and policymakers, we will develop optimization webtools for different settings. This proposal leverages the substantial advances in pediatric HIV simulation modeling made by the CEPAC-P team in the prior cycle to address the full range of approaches that will be needed to achieve ambitious global goals of eliminating pediatric AIDS. This work directly addresses NICHD research priorities: “efficient use of next-generation preventive and therapeutic technologies and prevention of HIV acquisition and illness in women and infants.” It also uses novel optimization methods to bring the results of complex models closer to policymakers to improve outcomes for mothers and infants affected by HIV worldwide.

Public health relevance
Progress toward elimination of pediatric HIV infection has stalled in recent years, primarily due to gaps in care for pregnant and lactating women with HIV and their infants. We propose to use a validated computer simulation model of mothers and infants to estimate and compare the clinical and economic impacts of alternative maternal interventions (HIV testing, pre-exposure prophylaxis, and antiretroviral therapy) and infant interventions (postnatal prophylaxis and testing), incorporating critical interactions between maternal treatment and infant prophylaxis and diagnosis. We will then develop, test, and apply simulation optimization methods and translate these results into online decision tools, to identify the packages of maternal and infant interventions that maximize clinical benefit and cost-effectiveness in a range of settings that reflect global variation in HIV epidemiology, healthcare delivery, and healthcare costs.